Differential Regulation of Tumor Invasion by RSK Family Isoforms

PROJECT ABSTRACT Cancer invasion causes debilitating tissue and organ destruction and leads to deadly metastatic disease. As such, understanding, preventing, and treating the aberrant motility of cancer cells is a high priority cancer research challenge. Our laboratory recently discovered that ERK and its effector p90RSK promote cell motility. These kinases are activated by common oncogenic mutations in receptor tyrosine kinases, RAS, and RAF. Interestingly, our work and that of others suggests that the p90RSK protein family members (RSK 1-­4) are not equivalent in their activity on specific substrates and ability to promote invasion. Indeed, the RSKs have been found to either promote or inhibit cell motility, depending on specific cancer types. A major rationale for this proposal is that the RAS®?RAF pathway is currently being targeted therapeutically and clear understanding of the role of each RSK family member in tumor cell motility would lead to improved therapeutic design and patient selection in clinical trials. The immediate goal of this application is to determine the role of each RSK homolog in lung cancer invasion and to identify the substrates involved in any functional specificity. We will integrate the analysis of human cell lines and murine tumor invasion models to: 1) determine which RSKs regulate non-­small cell lung cancer invasion and 2) determine the mechanisms by which relevant RSK homolog contributes lung cancer invasion. This work will pave the way for future efforts to specifically target and inhibit RAS pathway components that promote tumor invasion.

Public health relevance
PROJECT NARRATIVE Cancer invasion is the most significant cause of cancer morbidity and mortality. This application will test the central hypothesis that the members of RSK family of protein kinases differentially regulate lung cancer invasion and progression.